Crosstalk between chronic ER stress and mitophagy for the treatment of POAG

Abstract
Primary Open Angle Glaucoma (POAG) is the most common form of glaucoma that leads to irreversible vision
loss. Elevated intraocular pressure (IOP) due to dysfunction of trabecular meshwork (TM) tissue is a hallmark of
POAG. However, the pathological mechanisms leading to TM dysfunction and IOP elevation are poorly
understood. Our recent studies have shown that chronic endoplasmic reticulum (ER) stress is associated with
the pathophysiology of glaucomatous TM damage and IOP elevation. However, the exact mechanisms of TM
cell dysfunction/loss are not completely understood. The ER and mitochondria communicate constantly via
mitochondria-associated ER membranes (MAMs) to regulate vital cellular functions including autophagy.
Autophagy degrades long-lived proteins and damaged organelles including mitochondria (known as mitophagy)
via lysosomes. Impaired mitophagy is known to cause abnormal accumulation of damaged mitochondria
resulting into cell death. In our preliminary studies, primary human TM cells exhibited an abundant mitochondria
and MAMs. Interestingly, human primary TM cells and TM tissues from POAG donor eyes demonstrated
increased accumulation of mitochondria. Moreover, chronic ER stress-induced transcriptional factors, ATF4 and
CHOP led to increased reactive oxygen species and impaired mitophagy in primary human TM cells. Our overall
goals are to define the role of MAMs and impaired mitophagy in TM dysfunction and IOP elevation in POAG and
to further target these pathways for the treatment of glaucoma. We hypothesize that chronic ER stress induces
impaired mitophagy and mitochondrial dysfunction, leading to TM dysfunction/loss and IOP elevation in POAG.
We will determine whether impaired mitophagy and mitochondrial dysfunction are associated with TM
dysfunction and IOP elevation in human and mouse glaucoma (Aim 1). We will further determine whether chronic
ER stress induces impaired mitophagy and mitochondrial dysfunction, leading to TM dysfunction/loss and IOP
elevation (Aim 2). Finally, we will perform proof-of-principle studies exploring whether the mitophagy enhancers
improve outflow facility and reduce elevated IOP in mouse models of glaucoma (Aim 3). We will utilize human
primary TM cells and post-mortem TM tissues from normal and glaucoma donor eyes, mouse models of
glaucoma and mitophagy flux reporter mouse model (mito-qc) as well as transmission electron microscopy
(TEM) and the Seahorse assays to determine the role of MAMs, mitophagy and mitochondrial dysfunction in TM
function and IOP homeostasis. The successful completion of the proposed studies will provide novel crosstalk
between ER stress and mitophagy and target the pathological mechanisms for the treatment of general POAG.

Public health relevance
Project Narrative The successful completion of this project will lead to insights into molecular pathways that cause trabecular meshwork dysfunction and elevation of intraocular pressure in glaucoma, a leading cause of irreversible vision loss. The results will provide pathological mechanisms involved in glaucoma and develop novel treatment strategies for glaucoma by targeting these pathologies.